Machine learning approaches for improving EEG data utility in SUDEP research

Project Summary
The parent R01 project will test the hypothesis that Sudden Unexpected Death in Epilepsy (SUDEP) cases
exhibit different clinical, electroclinical and imaging features that can be identified and validated (Aim 1) and then
incorporated into an individualized Bayesian risk prediction model (Aim 2). The study will compare SUDEP cases
with age/sex-matched living epilepsy patients to identify clinical features and biomarkers, focusing on
electroencephalography (EEG), electrocardiogram (ECG), and magnetic resonance imaging (MRI) data that are
easily obtained during routine clinical visits. Potential biomarkers include postictal generalized EEG suppression,
interictal ECG heart-rate variability, and decreased volume in limbic and brainstem regions on structural MRI
scans. To leverage state-of-the-art computational tools for biomarker discovery, the parent R01’s Aim 3 employs
artificial intelligence (AI) and machine learning (ML) techniques to uncover novel biomarkers from interictal EEG
data.
The proposed supplemental project is closely aligned with the parent R01’s Aim 3 and builds on the base
of augmented datasets and new AI/ML techniques. Our research team consists of SUDEP and AI/ML experts
with complementary expertise who are uniquely qualified to develop innovative analytic tools for EEG data AI/ML-
readiness. In Aim 1, we will develop ML models to enhance data interpretation. In Aim 2, we will employ data
augmentation techniques to improve the consistency of labeled EEG data from both SUDEP cases and living
epilepsy patient controls. Overall, this administrative supplemental proposal will further enrich the research aims
in our parent grant, and promote research rigor, transparency and reproducibility. Accomplishing these aims will
maximize the data utility and improve AI/ML-readiness in epilepsy research.

Public health relevance
Project Narrative One in 1000 people with epilepsy die every year due to Sudden Unexpected Death in Epilepsy (SUDEP). Identifying risk factors associated with SUDEP remains challenging due to the lack of large controlled datasets enabling rigorous analyses and development of comprehensive prediction models. Our study will address this critical unmet need by screening records of >40,000 patients from >85 epilepsy centers worldwide to obtain a nearly order of magnitude more cases and controls than any prior study, and applying innovative methods to test candidate biomarkers, leading to better understanding of SUDEP mechanisms and developing individualized risk models to better target patients for counseling and interventions.